Enhancing responses to mRNA-lipid nanoparticle vaccines via utilization of endogenous lipid function

ABSTRACT
mRNA - lipid nanoparticle (LNP) vaccines developed against SARS-CoV-2 proved to be a transformative
technology that saved millions of lives during the COVID-19 pandemic. In this vaccine platform, LNPs function
as both a delivery agent and a powerful adjuvant, but the mechanisms contributing to LNP adjuvanticity are not
fully understood, hindering future vaccine design. In this proposal I will investigate how selectively altering the
lipids within an LNP impacts biodistribution and cell-specific protein translation from mRNA following
intramuscular administration, and whether these alterations can promote stronger cellular and humoral adaptive
immune responses. Phosphatidylserine (PS) is a negatively charged phospholipid normally present on the inner
leaflet of a cell’s plasma membrane but can become exposed on the outer leaflet during apoptosis. When this
occurs, PS is sensed by scavenger receptors of phagocytic antigen presenting cells (APCs), triggering
phagocytosis. Globotriaosylceramide (Gb3) is a glycosphingolipid that promotes migration of germinal center B
cells from the dark zone to the light zone by enhancing a B cell receptor (BCR) signaling cascade that results in
a decrease of CXCR4 expression. By incorporating these endogenous lipids into LNP formulations, this proposal
will test if they can direct cell and tissue-specific protein expression from mRNA-LNPs, and if they can impact
humoral and cellular immune responses. In Aim 1 I will determine the cellular uptake pathway for these modified
LNPs in vitro and their biodistribution in vivo. In Aim 2 I will elucidate how incorporation of PS and Gb3 lipids
into LNPs impacts adaptive immune responses in vivo. Overall, I hypothesize that adaptive immune responses
to mRNA-lipid nanoparticle vaccines can be specifically modulated based on incorporation of endogenous lipids
into the LNP formulation. The ability to alter immune responses to mRNA-LNP vaccines by leveraging
endogenous lipid function within an LNP would be hugely beneficial in creating more tailored, effective vaccines
against both existing and emerging infectious pathogens.

Public health relevance
PROJECT NARRATIVE Within the transformative nucleoside-modified mRNA vaccine platform, lipid nanoparticles (LNPs) function as both an mRNA delivery agent and a powerful adjuvant, but the mechanisms contributing to LNP adjuvanticity are not fully understood, hindering future vaccine design. In this proposal I will investigate how using endogenous, bioactive lipids within an LNP can promote stronger cellular and humoral adaptive immune responses. The ability to alter immune responses to nucleoside-modified mRNA-LNP vaccines by leveraging endogenous lipid function within an LNP would be beneficial in expanding this promising platform to create more tailored, effective vaccines against both infectious diseases and cancer.